Targeting brain myeloid cells with siRNA-lipid conjugates for treatment of Alzheimer's disease

Summary
Brain myeloid cells, including microglia and macrophages, selectively express several genes that confer risk for
late-onset Alzheimer’s disease (AD)—for example CD33, which regulates amyloid beta clearance. As such, there
is substantial interest in using oligonucleotide drugs—including siRNA—to knock down genes such as CD33 in
brain myeloid cells as a therapeutic intervention. However, it remains challenging to deliver siRNA to these key
cells in the brain. Oligonucleotide drugs are typically administered directly into cerebrospinal fluid (CSF), but free
siRNA is cleared rapidly and exhibits poor cellular uptake. To combat this issue, conjugation to lipophilic moieties
like cholesterol has been explored as a strategy to improve siRNA tissue retention and knockdown activity.
Unfortunately, current lipid modifications can impart dose-limiting toxicity and generate steep concentration
gradients around the injection site that cannot necessarily reach distal brain structures by diffusive transport. In
prior work, we have developed a novel diacyl fatty acid carrier for siRNA (“siRNA-EG18”) that binds albumin with
high affinity to extend circulation half-life of the conjugated siRNA. In the brain, albumin is transported effectively
along perivascular spaces that reach deep brain structures, leading us to hypothesize that siRNA-EG18 could
leverage convective perivascular transport to improve targeting of myeloid cells throughout the entire brain after
delivery into CSF. Our extensive preliminary and supporting data support this premise, where we have
demonstrated the ability of siRNA-EG18 to distribute through perivascular spaces and silence genes in brain
myeloid cells using both bulk and single-cell assays. Moving forward, Aim 1 will comprehensively analyze siRNA-
EG18-mediated bulk gene and protein silencing activity in brain myeloid cells as a function of injected dose. Aim
2 will extend these analyses into contexts of aging and amyloidosis and incorporate single-cell sequencing to
understand siRNA-EG18’s ability to target myeloid cell subtypes under disease-related conditions. Aim 3 will
focus on translation by benchmarking the efficacy of siRNA-EG18 against a lipid-siRNA conjugate that has
entered phase 1 clinical trials for early-onset AD. All aims will target Cd33 for its connection to myeloid cells and
late-onset AD. Successful completion of this work will establish siRNA-EG18 as a promising technology for AD
treatment through myeloid cell gene targeting.

Public health relevance
Narrative Oligonucleotide therapeutics such as short interfering RNA (siRNA) are promising candidates for treating Alzheimer’s disease (AD), but it remains challenging to deliver an efficacious dose of these therapeutics to relevant cell types in the brain. The goal of this proposal is to evaluate the ability of a novel siRNA-lipid conjugate, which can move effectively throughout the brain after administration in cerebrospinal fluid via perivascular transport, to silence an AD-relevant gene target in immune cells.